Characterization of assembly and activation of the Shigella type III secretion injectisome

PROJECT SUMMARY
Shigella causes bacillary dysentery with high worldwide morbidity and childhood mortality with complications
that include cognitive and developmental impairment in children suffering multiple diarrheal episodes each year.
Shigella’s main virulence factor is its type III secretion system (T3SS), which is used to deliver effector proteins
into host cells to promote pathogen entry. T3SSs are shared by many Gram negative pathogens with the
injectisome comprising a(n): 1) external needle and tip complex for delivering translocators and effectors; 2)
basal body that spans the bacterial envelope; and 3) cytoplasmic sorting platform (SP) that energizes and
controls secretion. We pioneered visualizing the SP by cryo-electron tomography (cryo-ET) and since then we
and others have identified the components of the SP. We now propose studies to explore structural differences
between the “on” and “off” secretion states for the in situ injectisome with parallel biochemical analysis of the SP
sub-assemblies and the first visualization of the Shigella injectisome-host membrane interface in situ. We will
use cryo-ET methods to view the SP pods at a 1-nm or better resolution and then use biochemical and molecular
methods as we develop models of assembly and function. In our investigation of the SP, we will explore the
movement of protein domains at the SP interface with the inner membrane ring. In parallel, we will extend our
study to examine another important cytoplasmic component of the injectisome - the export gate nonamer formed
by MxiA, which undergoes structural rearrangements in the absence of the SP. We will also exploit a system
we’ve generated for trapping different secretion substrates within the in situ injectisome so that we can determine
how the overall structure compares for three different states. These are the “on” injectisome (ipaD null strain)
and two forms of “off” injectisomes (mxiH null strain and effector-blocked strains), which will provide functional
insight into SP and export gate communication and association. We propose three complementary aims: 1)
Define the makeup, intermediate states and structural requirements at the SP/inner-membrane ring (IR) interface
that allow SP assembly and guide type III secretion. 2) Correlate export gate structural features with secretion
status using complementary cryo-ET and molecular methods; and 3) Identify the structural changes associated
with trapping substrates within the in situ injectisome and begin generating the first high-resolution picture of the
injectisome-host membrane interface in situ using cryo-ET. Improved cryo-ET methods provide an
unprecedented view of substructures within the Shigella injectisome in situ to reveal elements that cannot be
studied using purified needle complexes and this is reflected in the preliminary data presented here. We can
now visualize these sub-structures, target them for molecular analysis and purify them for in vitro biochemical
and biophysical analysis. The T3SS is an essential virulence determinant for many pathogens, but we still lack
the structural understanding needed to determine the mechanisms that underlie type III secretion.

Public health relevance
PROJECT NARRATIVE Shigellosis or bacillary dysentery remains a serious global public health problem, especially for children under the age of five. The ability for Shigella species to cause dysentery requires a functional type III secretion apparatus or injectisome which delivers host-altering effector proteins into the cells of the large intestine. This research will explore the assembly and function of the cytoplasmic portions of the injectisome by identifying key protein-protein interfaces and protein structural shifts that contribute to injectisome assembly, stability and function. These findings will lay the foundation for future development of small molecule inhibitors that will help in the treatment of bacillary dysentery.